Mechanistic Modeling of Cellular Systems

Project Summary
This proposal aims to continue operation of the National Resource for Mechanistic Modeling of Cellular
Systems, to serve the large community of cell and systems biologists. The Resource encompasses the
COPASI and Virtual Cell (VCell) software platforms, which are arguably the most comprehensive and widely
used tools for computational modeling of the biophysical mechanisms controlling cell function. VCell supports a
number of key biophysical mechanisms, including reaction kinetics, diffusion, flow, membrane transport, lateral
membrane diffusion, electrophysiology and rule-based models of multi-state/multimolecular interactions.
Simulations can be based on 0D, 1D, 2D or 3D analytical or experimental image-based geometries. Users may
choose among multiple available simulation approaches: ordinary differential equations, partial differential
equations, stochastic reaction kinetics, network-free simulations, spatial particle-based simulations and spatial
hybrid stochastic/deterministic simulations. COPASI enables the simulation and analysis of complex
biochemical reaction networks either deterministically or stochastically. It offers a broad range of analysis tools
including parameter estimation/optimization, steady state analysis, stoichiometric analysis, sensitivity analysis
and metabolic control analysis. VCell and COPASI each boast thousands of active users. From 2020-2024, the
Resource has supported research in 437 publications from a wide array of scientific fields, including
metabolism, cell signaling, cancer, aging, chemistry, biophysics, and others. The two software technologies
were also used to help develop a variety of new experimental methodologies. This support includes 77 NIH-
funded grants. The Resource will continue maintaining the software removing bugs and adapting it to new
developments in operating systems, as well as expanding their utility by adding other established
methodologies for modeling and simulation. Both VCell and COPASI are hosted at the University of
Connecticut School of Medicine and benefit from: (1) the common institutional organization under which they
operate; (2) a joint website; (3) a common high performance computing facility that serves the computationally
intensive needs of users without charges; (4) coordinated training and outreach to the user community in the
form of web-based documentation and tutorials, two yearly Computational Cell Biology Workshops and
numerous roadshows at national and international meetings. Additionally, VCell and COPASI are leveraged by
external systems biology software developers as user-friendly platforms for the wide dissemination of their third
party algorithms, software and databases. Finally, the Resource actively engages with the community of
researchers defining software standards to assure the reproducibility and reusability of both the software and
the models it generates.

Public health relevance
Project Narrative Computational modeling, enabled by COPASI and VCell technologies, will offer deep insights into mechanisms by which cells function and the cellular basis of disease. Projects by the users of this National Resource focused on cancer, neurological disorders, diabetes, kidney disease, cardiology and aging, for example, all utilize mathematical models developed with the aid of VCell and COPASI.